Using Novel Machine Learning Approaches to Understand Subgingival Microbiome Heterogeneity in Relation to Health and Disease

Project Summary
Periodontitis is a complex disease marked by progressive inflammation and destruction of the tissues and bone
supporting teeth. Subgingival microbiome dysbiosis is a hallmark of periodontitis with dramatic compositional
shifts observed between periodontal health and severe periodontitis. However, there is limited knowledge on the
inter-individual variability in subgingival microbiome in large cohorts presenting diverse periodontal phenotypes
varying in extent and severity and potentially influenced by systemic comorbidities and exposures. Moreover,
most current knowledge on the subgingival microbiome is based on species-level taxonomies, failing to capture
strain-level variability which is an important determinant of bacterial virulence. Such detailed understanding of
microbiome heterogeneity is needed to elucidate associations of different microbiome states with clinical
phenotypes and periodontitis progression. This proposal aims to address these knowledge gaps by leveraging
existing population-based cohorts encompassing cross-sectional and 5-year longitudinal follow up datasets and
employing advanced machine learning techniques, which enable to capture intricate, nonlinear patterns in
microbiome distributions. Our hypothesis is that different microbiome states associated with periodontitis clinical
phenotypes and host characteristics exist and can predict periodontitis progression. In Aim 1 (K99 phase), we
will use manifold learning techniques to construct microbiome landscape models using cross-sectional 16S data
from two large cohorts encompassing over 2,600 subjects. We will identify heterogeneous microbiome states
and their relationships with periodontitis phenotypes, and will then examine the predictive ability and dynamics
of these microbial states in relation to periodontitis progression over a 5-year period. In Aim 2 (K99/R00 phase),
we will refine strain profiling methodologies and establish a strain-level landscape model using metagenomic
sequencing to identify variations in strain compositions and functional alterations correlated with periodontitis
phenotypes. Upon successful completion of these specific aims, our research is expected to provide a
comprehensive understanding of the subgingival microbiome heterogeneity elucidating different microbiome
states and their associations with periodontitis offering opportunities for developing targeted, personalized
treatment strategies. The application of machine learning techniques is a significant advantage, enabling the
analysis of large, complex datasets and the discovery of patterns and relationships that traditional statistical
methods can not reveal. The training phase of this proposal will be conducted under the guidance of an
experienced mentorship team, equipping Dr. Lu Li with expertise in microbiome analysis, epidemiology and
bioinformatics. Additionally, training in scientific communication, grant writing, and leadership skills will be
provided, essential for establishing a successful independent research career. The mentorship team will offer a
collaborative and intellectually stimulating environment, fostering the development of my scientific career as an
independent investigator and ensuring successful project completion.

Public health relevance
Project Narrative The proposed research will use an integrative approach coupling population-based oral microbiome data with novel machine learning techniques to understand species and strain level microbiome heterogeneity and its relationship to periodontitis clinical phenotypes also accounting for various environmental and medical exposures. The findings of this study will significantly advance our understanding of the subgingival microbiome elucidating different microbiome states and their associations with periodontitis offering opportunities for developing targeted, personalized treatment strategies. This study aligns closely with the special interest of NIDCR (NOT-DE-23-002) that calls for projects utilizing data science resources and methods for dental, oral, and craniofacial research.